Studies of Transfer RNA

PROJECT SUMMARY (of the parent award R35GM122560)
Proteins are typically synthesized with 20 amino acids, yet over 300 amino acids are found in proteins as
a result of posttranslational modifications (PTMs). These natural noncanonical amino acids (ncAAs) mod-
ulate protein function and control fundamental cellular processes. Satisfactory genetic encoding of ncAAs
requires the development of efficient and accurate aminoacyl-tRNA formation and delivery to the ribosome
by design of tRNAs, tRNA synthetases, and elongation factors that constitute orthogonal translation
systems (OTSs). While some ncAAs have been genetically encoded (e.g., N-acetyllysine, phosphoserine
(Sep)), OTSs have not been established for a number of critical PTMs. The overall goal of this proposal is
to rewire translation by developing OTSs for facile and precise production of natural and engineered
proteins containing naturally occurring and synthetic ncAAs. These general goals will be realized in three
specific areas of the proposed work. (1) Selenium, in the form of selenocysteine (Sec), is an essential trace
element for human health, exhibiting many advantageous chemical properties with its misincorporation
implicated in many disease states. We will engineer efficient site-directed insertion of Sec and investigate
the effects its insertion along with its precursor Sep into several enzymes of industrial and medical interest.
(2) While the genetic code was once thought to be universal, natural codon reassignments in nature are
now known to be widespread. We will couple bioinformatic analysis with our knowledge of tRNA identity
elements to both reveal novel genetic codes and better characterize the role of this variability in nature.
Additionally, we will use long-term evolution to produce an organism with a new genetic code utilizing
synthetic amino acids. (3) We plan to create aminoacyl-tRNA synthetases for efficient synthesis of
ncAAtRNA for a series of phosphoamino acids and chemically reactive synthetic amino acids. Given the
critical role of phosphorylation in cell signaling and the success of kinase inhibitors against cancer cells,
and based on our success establishing an OTS for phosphoserine, we propose to establish OTSs for
additional phosphoamino acids and their non-hydrolyzable analogs. Incorporation of chemically reactive
amino acids will provide a robust tool to introduce PTMs, biophysical probes, or other valuable residues
into a protein of interest. The proposed work is significant because the ability to produce, purify,
biochemically and structurally characterize proteins containing ncAAs at defined sites is essential for
elucidation of fundamental cellular processes and for construction of new tools for protein design. The
innovation of the proposed work is to genetically encode these biologically relevant ncAAs, and provide
efficient OTSs for biochemical and biomedical researchers to help unravel the complex network of PTMs
and their role in biotechnology and human health.

Public health relevance
PROJECT NARRATIVE (of the parent award R35GM122560) The unexpected diversity of aminoacyl-tRNA synthesis (processes that maintain the coding relationship between DNA and protein) opens previously inaccessible frontiers in the biology of translation and post- translational protein modifications, the malfunction of which is linked to several human diseases including cancer, neurodegenerative and metabolic disorders. The proposed projects aim to design new routes for aminoacyl-tRNA formation and create orthogonal translation systems to site-specifically incorporate natural non-canonical amino acids (ncAAs), which is relevant to human health because the ability to produce proteins containing ncAAs at defined sites will allow elucidation of molecular mechanisms for basic cellular processes including apoptosis, gene expression, and cellular signaling networks in healthy and diseased human cells. These studies will ultimately provide valuable pharmacological targets and novel therapeutic interventions for a variety of human diseases including cancers and genetic disorders.